BIOSPECIMEN PROCESSING CENTER (BPC) - EARLY ONSET MALIGNANCIES INITIATIVE

This Task Order provides support to the Early Onset Malignancies Initiative (EOMI). The EOMI is a collaborative initiative between CCG and the Division of Cancer Prevention’s NCI Community Oncology Research Program (NCORP) investigating why certain racial and ethnic populations are at increased risk of developing cancer at an early age, The EOMI will focus on six cancer types that in certain minority populations develop at an earlier age, occur in higher rates, and are typically more aggressive. The Center for Cancer Genomics (CCG) Biospecimen Processing Center (BPC) supports the EOMI genomics projects by providing the following services: Biospecimen and associated Data Procurement, Biospecimen Management and Biorepository Operations, Biospecimen Histological Review, Biospecimen Processing into Molecular Analytes, and Biospecimen and Analyte Distribution.